Genetic and Environmental basis of Cancer Risk and Disparities (GECaRD)

This proposal is for a new T32 predoctoral program to train the next generation of cancer researchers with expertise in examining complex factors influencing cancer risk. The rationale for this T32 is to integrate multiple fields of cancer research through cross-disciplinary education and professional development. The program utilizes the strengths of Stanford University and Silicon Valley to offer specialized training in cancer research through a combination of coursework, seminars, internships, and mentored projects. Coursework and seminars include core offerings developed for this program. Trainees will acquire skills in key cancer research disciplines, including epidemiology, biostatistics, genetics, omics, and environmental health. The program also introduces trainees to the multifactorial influences on health outcomes, spanning biological, social, and environmental domains. The T32 will emphasize both technical and interpersonal skills such as advanced research methods, data analysis, communication, teamwork, and leadership. Training will be grounded in the principles of responsible research conduct. Drs. John Witte and Melissa Bondy lead the program having overseen multiple previous training programs and with decades of successful experience training the future generation of cancer researchers. The T32 mentoring team is comprised of 26 outstanding faculty members with cancer-focused research projects across scientific disciplines. The program has extensive financial and administrative support for trainees from Stanford University and the Stanford Cancer Institute, rigorous student advising, and evaluation among the trainees, mentors, an internal executive committee, and an external advisory committee. By integrating multiple approaches, the T32 has a strong foundation in which trainees develop the skills vital for furthering their careers in research to decipher the causes of cancer and contribute to the development of more effective prevention and treatment strategies of this common, but complex disease.

Public health relevance
Furthering the ongoing fight against cancer requires scientists who can communicate across traditionally distinct research disciplines such as epidemiology, biostatistics, genetics, -omics, and environmental health. The proposed T32 program will fulfill this need by providing exceptional training to prepare predoctoral students in the integration of innovative methods and cancer research questions in a cross-cutting transdisciplinary and translational manner. Graduates of the program will have the expertise to work in multidisciplinary teams and be tomorrow’s cancer research leaders.